Early life adversity as a modifier of recovery after traumatic brain injury to the developing brain.

Project Summary
These studies will determine if early life adversity (ELA) impacts recovery after traumatic injury to the
developing brain. ELA refers to a broad spectrum of stressful events, including maternal neglect, and there is
substantial evidence implicating ELA in later life poorer mental and physical health. A current model links ELA
to “biological embedding”, whereby allostatic neurobiological pathways promote the enduring effects of ELA.
Here I will focus on two of these ELA pathways, the immune system and redox state, as modifiers of recovery
after an early age traumatic brain injury (TBI). I will study ELA, resulting from fragmented maternal care during
a critical period of brain development [(postnatal day (P) 2-9], in combination with a well-established model of
focal injury to the cerebral cortex in mice at postnatal day p21, an age that approximates the toddler-aged
child. We and others have demonstrated that the brain at p21 is particularly vulnerable to oxidative stress and
shows a unique sensitivity to inflammatory cytokines, corresponding to a more pronounced disruption of the
blood-brain barrier (BBB) and leukocyte recruitment, compared to the injured adult brain. Based on these
collective findings, I hypothesize that ELA enhances neuroinflammation, BBB disruption, and oxidative
stress in the acutely injured brain and promotes long-term cognitive and social deficits. To test this
hypothesis, Specific Aim 1 will determine if ELA has an additive or synergistic effect on inflammation when
combined with TBI. Flow cytometry will be used to profile circulating and brain-infiltrated myeloid lineage cells
and pro-inflammatory cytokines will be measured by ELISAs in serum and brain homogenates. Specific Aim 2
will determine if ELA supports acute secondary pathogenesis after TBI. Western immunoblots will be used to
detect oxidative stress, BBB disruption, and cell damage. Complimentary histology will assess cell injury,
microglial activation, and barrier leakage to FITC-tagged dextrans. Specific Aim 3 will determine if ELA
disrupts long-term functional and structural recovery after TBI. I will assess anxiety-like behaviors, learning and
memory, and social behaviors at adulthood. Lastly, stereology will be used to quantify cortical and
hippocampal volumes and neurons in CA1, CA2, and CA3. Together, these studies offer the first insights into
how ELA may influence secondary damage and recovery after an early age TBI. Such findings offer a
foundation for developing strategies that are uniquely tailored to those brain-injured children who have
experienced ELA.

Public health relevance
Project Narrative Clinical studies and pre-clinical models of traumatic brain injury (TBI) to the developing brain show a unique neuroinflammatory response and presence of oxidative stress, contributing to secondary pathogenesis and functional deficits after injury. Similarly, developmental models of early-life adversity (ELA) reveal that exposing mouse pups to prolonged stress during postnatal life results in a neuroinflammatory response, oxidative stress, and long-term deficits in functional outcomes. With no studies to date linking the two areas of research, the aim of this proposal is to understand the relationship between ELA and a subsequent TBI and how the overlapping mechanisms influence long-term recovery after a TBI to the developing brain.